Mitochondrial Energetics, Circuits and Cognitive Decline in the Aging Human Brain

PROJECT SUMMARY
The brain-wide networks that enable cognitive functions rely on the availability of large amounts of energy. Most
of the brain’s energy is generated by mitochondria, unique organelles with their own DNA (mtDNA) that populate
the cytoplasm of all cell types. Recent studies suggest that mitochondrial energetics are a rate-limiting step in
healthy neural function, and mitochondrial dysfunction contributes to Alzheimer’s disease (AD) and other forms
of dementia and psychopathology. Two lines of work from our group has contributed support to this hypothesis.
First, we have examined the ROSMAP cohort, a large-scale study with longitudinal (up to 20 years)
neuroimaging, cognitive, and clinical measures prior to death, with comprehensive assessments of postmortem
brain pathology. Our multi-omic data in >500 postmortem ROSMAP samples of dorsolateral prefrontal cortex
has identified gene expression, protein abundance, and mtDNA copy number differences in AD, which indirectly
suggest alterations in mitochondrial function. Second, we have access to a unique cohort of individuals with rare
genetically-inherited primary mtDNA disorders (MITO), which allow us to examine more directly the influence of
mitochondrial dysfunction on the brain. Our MITO cohort exhibits signs of cognitive deficits across multiple
cognitive domains implicating prefrontal brain areas. Therefore, in this project, we have assembled a
transdisciplinary team capable of integrating sensitive measures of cognitive reserve, tissue mitochondrial
function, and multivariate neuroimaging-based pattern recognition and network models. In Aim 1, we deploy our
mitochondrial phenotyping platform optimized for brain tissue to characterize mitochondrial dysfunction across
eight brain regions (6 grey matter, 2 white matter tracks) in n=500 individuals from ROSMAP. We will use this
dataset to develop well-powered statistical models testing mitochondrial function, separately for each region or
as a global aggregate across 8 regions, as a predictor of cognitive outcomes, including cognitive reserve –
preserved cognition function despite abundant pathology. In Aim 2, we leverage functional and structural
neuroimaging data collected prior to death in the same individuals to build neuroimaging-based predictive models
of i) regional and global mitochondrial dysfunction and ii) cognitive reserve. In Aim 3, to examine structural and
functional brain alterations associated with specific, highly penetrant primary mitochondrial defects, we conduct
neuroimaging and neuropsychological studies in our rare MITO cohort with mtDNA defects without the
confounding effect of advanced age or dementia. These analyses will allow us to identify common brain features
linked to mitochondrial dysfunction across both ROSMAP and MITO cohorts. Combined, our direct
measurements of mitochondrial function across multiple brain regions provides a unique opportunity to examine
the energetic basis of normal and abnormal connectivity in the human brain, and opens opportunities for future
translational studies in living subjects at risk of AD.

Public health relevance
NARRATIVE Mitochondrial dysfunction is an emerging mechanism of Alzheimer’s disease (AD) pathogenesis, but mitochondrial function has not been assayed at scale in human brains or linked to other key measures, such as longitudinal clinical assessment and neuroimaging. In this project, we apply a novel mitochondrial phenotyping platform to systematically establish signatures of mitochondrial (dys)function across multiple grey and white matter regions in 400 patients from the ROSMAP cohort, and link these postmortem mitochondrial measures to longitudinal antemortem cognitive and neuroimaging measures. Finally, leveraging ROSMAP and another unique cohort with genetic mitochondrial dysfunction, we develop neuroimaging-based predictive models of mitochondrial dysfunction across both cohorts, providing the community with the first large-scale dataset of brain mitochondrial energetics and a model of how mitochondrial function relates to structural and functional brain networks.